Use of IPSC to define role of astrocytes in specifying risk for onset of cerebral adrenoleukodystrophy

PROJECT SUMMARY/ABSTRACT
The mechanism of disease progression from benign to fatal phenotypes in X-linked adrenoleukodystro-
phy remains unknown and there is no satisfactory cure for the disease. 60% of male X-ALD patients develop
fatal cerebral disease (cALD) while the remaining 40% develop milder adrenomyeloneuropathy (AMN) charac-
terized by axonopathy. The primary genetic defect in X-ALD (mutation/deletion in ABCD1 gene) and the bio-
chemical defect (accumulation of very long chain fatty acid; C>22:0 in plasma and tissues) cannot predict the
onset of AMN or cALD. The long-term goal is to contribute to the development of novel clinically useful, mecha-
nism-based prognostic indicators and therapeutic options for X-ALD. The overall objective for this application is
to determine differential metabolic energy metabolism underlying phenotype variability (AMN vs cALD) in the
human astrocytes of male X-ALD phenotypes. The central hypothesis is that altered metabolic reprogramming
underlies the differential phenotype development in AMN and cALD astrocytes. These astrocytes were differen-
tiated from induced pluripotent stem cells (iPSCs), which, in turn, were generated by reprogramming of human
control, AMN and cALD patient-derived fibroblasts. This hypothesis is supported by untargeted metabolomics
pilot data identifying metabolites altered between healthy-control and cALD phenotype postmortem brain and
between AMN and cALD astrocytes. Within the cALD brain white matter, unique metabolite changes were rec-
orded between distant normal looking areas and areas adjacent to the plaque suggesting an association with
disease progression. OXPHOS and glycolysis were found to be decreased (low metabolic state) in human cALD
astrocytes. This low metabolic state suggests a role for novel alternative source(s) of fuel driving the progression
to cALD phenotype in astrocytes. The rationale for the proposed research is that a mechanistic modelling of
aberrant energy metabolism in AMN and cALD astrocytes will provide a basis for predicting disease progression
and new opportunities for identification of targets for novel therapeutic drug design. The central hypothesis will
be tested by pursuing two specific aims: 1) Determine the role of metabolic reprogramming in newly “forged”
AMN and cALD astrocytes; and 2) Determine the contribution of mitochondrial dysfunction in metabolic repro-
gramming in AMN and cALD astrocytes. The approach will take advantage of control, AMN and cALD astrocytes
recently generated from iPSCs in the laboratory. This proposal is innovative because it departs from the status
quo by identifying for the first time, metabolic pathways differentially altered in human AMN and cALD astrocytes.
The proposed research is significant because the cellular mechanism(s) that lead to less severe AMN or fatal
cALD phenotype in response to same ABCD1 mutation remain unknown even four decades after the identifica-
tion of gene defect in X-ALD. Successful completion of the proposed research is expected to provide a necessary
conceptual framework for the subsequent development of clinically effective strategies for predicting disease
progression and improving current limited treatment options.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because our approach will establish the mechanism of disease progression in fatal cerebral phenotype of X-linked adrenoleukodystrophy, a genetic disorder that in 2016 was added to the federal Recommended Uniform Screening Panel of all genetic diseases recommended for state newborn screening programs. The identified metabolic pathways upon completion of the proposed research can be potentially translated to the clinical laboratory setting for drug development. The proposed research is relevant to the part of the NINDS mission that pertains to acquiring and using fundamental new knowledge of the nervous system to decrease the burden of neurological disease.